Cross-Disciplinary Neural Engineering (CDNE) Training Program

Project Summary
The Cross-Disciplinary Neural Engineering (CDNE) predoctoral training program will train the future
research leaders able to bridge across the disciplinary boundaries of engineering, sciences and
mathematics to neurosciences and the treatment of human brain health. Such leaders are necessary
to produce lasting and relevant engineering, scientific and medical findings that will lead to improved
human health. The CDNE program build from the strengths of the affiliated graduate programs and
Penn State’s Center for Neural Engineering to create a new training program focused on cross-
disciplinary training for graduate students. Trainees coming from a range of disciplinary programs
including engineering, physics, mathematics and neuroscience graduate programs will complete a
common neuroscience course core; be co-mentored by at least two trainers across disciplinary realms
of Materials and Devices, Theory and Computation, Brain Physiology, and Human Brain Health; and
participate in a range of activities designed to enhance cross disciplinary communication and
collaboration, quantitative approaches, and scientific rigor. The CDNE will augment existing graduate
programs in Engineering Science and Mechanics, Mechanical Engineering, Electrical Engineering,
Mathematics, Physics, Anthropology, Neuroscience, and Biomedical Engineering, to provide
specialized training in neural engineering. The CDNE program will fund the training of a total of 15
graduate students during the five years by a combination the NIH (10) and PSU (5) funded fellowships.
Each trainee will be supported for a two-year period starting in their 3rd year. Trainees will gain
experience working across disciplines and able to be both experts in one domain, and able to
understand the language, science needs of other domains and thereby make significant contributions
bridging across both.

Public health relevance
Project Narrative There is a need in the science and medical health fields associated with brain for expert contributions from engineering, sciences and mathematics in order to make lasting advances. The proposed Cross Disciplinary Neural Engineering (CDNE) training program will train future leaders in the field of neural engineering able to work across the disciplinary boundaries of engineering, sciences, mathematics, and neurosciences and human brain health. CDNE trainees will be able to communicate and understand deeply the needs and science of their collaborators, and thereby able to produce lasting advances in both basic neurosciences and the treatment of human brain health.